Clinical Validation of Myoelectric Implant for Intuitive Prosthesis Control

Abstract
The goal of this translational NIH SBIR program is to evaluate a small, implantable system for recording
myoelectric signals from residual muscles of individuals with forearm amputations. The signals will be wirelessly
coupled to an external transceiver for controlling a prosthesis. Compared to conventional surface electrodes,
this system will provide:
• more channels for prosthesis control from a larger number of muscles in the residual limb,
• improved specificity and repeatability for recording from individual muscles and muscle groups,
• higher reliability and quality for the recorded signals under different socket conditions,
• selective, consistent signals from deep muscles, and
• the ability to use gel, vacuum, and other prosthesis socket lining systems that do not easily accommodate
surface electrodes.
These multichannel recordings will enable users to generate simultaneous multi-axis movements with a more
natural feel of control than existing myocontrollers that only actuate a single joint axis at a time. In Phase I, we
will complete upgrades and testing of the external transceiver to eliminate the need of the belt-worn processor.
In Phase II, we will conduct an early feasibility IDE study in conjunction with the University of Pittsburgh. We will
coordinate nationwide recruitment along with Advanced Arm Dynamics to enroll a sufficient number of subjects
to implant 5 subjects with the myoelectric implant for a 1-year study. Subjects will be implanted and undergo
quarterly evaluation at the University of Pittsburgh throughout the 1-year take-home study. The implant will be
evaluated for safety and efficacy for controlling a multi-articulating prosthetic limb.

Public health relevance
Narrative The implantable myoelectric sensor evaluated in this program will provide fundamental improvements in the usability and reliability of prosthetic arms, wrists, and hands. The multi-channel recordings provided by the system will enable prosthesis users to produce coordinated, multi-joint movements with a more intuitive and natural feel than existing systems.